Engineering Siglec15/TGF-beta targeted bispecific antibodies that modulate the tumor microenvironment and enhances T-cell immunotherapy against pancreatic cancer

Pancreatic ductal adenocarcinoma (PDAC), which accounts for more than 90% of the pancreatic
cancer cases, unfortunately has an average 5-year survival rate of less than 10%. To date, both chemotherapy
and immunotherapy, including the checkpoint inhibitors like PD-L1, CTLA-4, has not been effective in treating
PDAC. Although PDAC is infiltrated with leukocytes, they are mostly the suppressive types such as myeloid-
derived suppressor cells, regulatory B cells, T regulatory cells and M2-macrophages, likely due to elevated
levels of molecules such as TGF-β that suppresses T-cell activation.
We have identified Siglec-15 (S15), which can directly inhibit NFKβ/NFAT signaling resulting in
suppressed T-cell proliferation and cytokine production, as a critical immune suppressor in tumor
microenvironment. Interestingly, S15 is broadly upregulated in various cancers, including triple negative breast
cancers and PDAC, as well as tumor-associated macrophages, with no detectible expression in other healthy
cells besides monocytes. Elevated expression of S15 is correlated with poor survival in PDAC patients.
Importantly, Siglec15 is highly expressed in PDAC cells with low PD-L1, suggesting Siglec15 may be involved
in immune evasion observed in PDL1-negative PDAC.
Given the overexpression of S15 in PDAC, we hypothesized that a bispecific antibody (bsAb) that
binds both S15 and an immune-suppressive cytokine (TGF-β) could result in greater bsAb accumulation in the
tumor, and thus synergistically enhances T-cell activation for improved tumor suppression. We hypothesize
that bispecific T-cell engagers (BiTE) that bind S15 and CD3 could likewise enhance T-cell immunotherapy
against PDAC, including breaking down the stromal barrier. In pilot studies, our S15/TGF-β bsAb afforded
much more effective tumor suppression than a cocktail of anti-S15 and anti-TGF-β Ab in mouse model of triple
negative breast cancer. Likewise, S15/CD3 BiTE effectively suppressed pancreatic tumor in a xenograft model.
Building off these promising findings, we seek to explore whether simultaneously modulation of the
tumor immune microenvironment with improved T-cell targeting can lead to more effective therapy against
PDAC. Towards this goal, we will engineer in Aim 1 a panel of bsAb that binds S15 while possessing different
number of binding domains against TGF-β. We will evaluate whether the increased number of TGF-β binding
domains further reduce immune suppression in the tumor leading to more effective therapy in an orthotopic
pancreatic model in mice. In Aim 2, we will investigate whether the most potent S15/TGF-β bsAb from Aim 1
may synergistically enhance S15/CD3 BiTE therapy, both in an orthotopic human pancreatic cancer model in
NSG mice infused with human PBMC and in a syngeneic orthotopic mice pancreatic cancer model. If
successful, our work may lead to improved treatment options for management of PDAC, as well as advance an
overall framework to enhance immunotherapy against different cancers.

Public health relevance
Narrative Pancreatic ductal adenocarcinoma continues to be one of most deadly malignant diseases due to the tumor’s highly immunosuppressive nature. In this proposal we seek to engineer dual-target binding antibodies that can preferentially bind pancreatic cancer cells and inhibit immunosuppressive molecules within the tumor, while also better engaging immune cells to eliminate the pancreatic cancer cells. If successful, our work may introduce a promising therapeutic strategy for improved treatment of pancreatic cancer.